VIRAL ACTIVATION TRANSFUSION STUDY (N01-HB-57122)

The present study is designed to determine in transfusion of allogenic blood to HIV-1 infected persons leads to immune activation and consequent induction of HIV-1 and/or CMV replication, and whether this adversely affects clinical prognosis.